Stimulant for stem cell expansion in vivo to speed recovery of neutropenia secondary to chemotherapy and stem cell transplant

PROJECT SUMMARY
Hematopoietic stem cell (HSC) transplants (HSCTs) are considered a potentially curative option for patients with
certain cancers of the blood and bone marrow, and over 20,000 HSCTs are performed in the US each year.
However, HSCTs are associated with high risk due to the required removal of diseased bone marrow before
transplantation. Until the transplanted cells engraft and proliferate enough to reconstitute the patient’s immune
system, the patient is considered neutropenic, during which time they are highly susceptible to infection. In
addition to the potentially life-threatening physical risk to the patient, neutropenia necessitates long
hospitalization time that can in part drive the expensive cost of HSCTs ranging from $200,000-400,000 in the
US depending on donor cell type. A current strategy in clinical trials is to transplant larger pools of donor HSCs
to shorten the neutropenic phase. However, currently investigated HSC expansion approaches will all rely on
long-term (~3-week) ex vivo culturing of donor cells that depend on imperfect man-made culture systems that
may disrupt the proper function of the stem cells and can be prohibitively expensive.
Ship of Theseus’ innovative solution is a drug that will be used for a short, 24-hour exposure time to donor cells
prior to transplantation that improves expansion in vivo. Our drug is a patented mutant of Homeobox protein B4
(HOXB4m). HOXB4 is well-established to promote HSC expansion without altering differentiation. However, its
progression to the clinic was stopped because the half-life of HOXB4 protein was too short to be practical for
clinical use and genetically overexpressing HOXB4 resulted in myeloproliferative disorders. Our patented, cell-
penetrating/nuclear-targeting mutant has improved degradation resistance, elongating its intracellular half-life
enough to be practical for clinical use while potentially avoiding adverse effects induced by constitutive
overexpression. In our Phase I project, we successfully demonstrated rapid and diverse short-term bone
marrow cell expansion in vitro, short-term reduction of neutropenic phase in vivo, and long-term
hematopoietic reconstitution in vivo upon HOXB4m treatment.
The goal of this Phase II SBIR proposal is to perform IND-enabling safety, pharmacokinetic/pharmacodynamic
(PK/PD) while also optimizing the clinical protocol. This will be accomplished through two aims. In Aim 1, we will
extend in vivo efficacy confirmation to a 24-hour incubation with HOXB4 protein tagged with a novel proprietary
cell penetrating/nuclear-targeting peptide optimized in vitro in a mouse model of HSCT. In Aim 2, we will
manufacture HOXB4m under GMP and conduct definitive toxicology and PK/PD studies in mice. Successful
completion of this Phase II program will provide the necessary data to support an IND submission and
eventual Phase I clinical trials. With HOXB4m, we can circumvent the original hurdles of HOXB4 and improve
expansion in vivo to benefit HSCT patients by shortening the neutropenic phase to reduce infection,
hospitalization time, and cost.

Public health relevance
PROJECT NARRATIVE Over 20,000 hematopoietic stem cell transplants are performed each year in the US and are used to treat certain cancers of the blood and bone marrow. Diseased bone marrow is removed and replaced with healthy cells, but patients are at high risk for infection and other life-threatening inflammatory conditions until the healthy cells expand enough to restart the immune system. Ship of Theseus has developed a therapeutic strategy to shorten this window of risk and improve patient outcomes by briefly treating donor cells with their novel drug, HOXB4m, to increase the rate of expansion of hematopoietic stem cells in the patient without depending on extensive cell expansion outside of the patient.